FSMA Human Foods Preventive Controls Implementation Expansion Supplement: Washington State Department of Agriculture

Flexible Funding Model- FSMA Human Foods Preventive Controls Implementation Expansion Supplement to RFA-FD-18-001 Project Summary This strategic plan outlines the Washington Department of Agriculture’s (WSDA) multi-year strategy to promote compliance with the Current Good Manufacturing Practice, Hazard Analysis, and Risk based Preventive Controls for Human Food (PCHF) regulation. The intent is to expand our ability to implement the PCHF Rule which advances efforts for a nationally integrated food safety system by encouraging the safe manufacturing and processing of food and promoting understanding and compliance with the requirements of the PCHF Rule. This proposal explains how we intend to increase the number of staff that are proficiently trained to independently perform high quality full scope PCHF inspections. A related component is the development of auditors to effectively review the full scope PCHF inspection performance skills of these inspectors. We seek to assist industry through outreach to aid their understanding of the PCHF expectations and support them to successfully develop PCHF compliant food safety manufacturing and monitoring systems. We also recognize the importance of mutual reliance and seek to expand our new database while it is still being developed to allow it to communicate with FDA. This enhanced electronic communication and meetings about cooperative enforcement will support FDA’s overall goals of food safety, mutual cooperation and efficient work planning while supporting the Food Safety and Consumer Service’s mission to promote food integrity, safety and availability.

Public health relevance
Project Narrative The Washington Department of Agriculture intention is to expand our ability to implement the PCHF Rule which advances efforts for a nationally integrated food safety system by encouraging the safe manufacturing and processing of food and promoting understanding and compliance with the requirements of the PCHF Rule. This proposal explains how we will increase the number of staff that are proficiently trained to independently perform high quality full scope PCHF inspections. A related component is the development of auditors to effectively review the full scope PCHF inspection performance skills of these inspectors. We also seek to assist industry through outreach to aid their understanding of the PCHF expectations and support them to successfully develop PCHF compliant food safety manufacturing and monitoring systems.